Chemical strategies to investigate biochemical crosstalk in human chromatin

PROJECT SUMMARY
This Administrative Supplement is for the purchase of a CEM LibertyPrime2.0
microwave-assisted peptide synthesizer designed for Fmoc-based solid-phase
peptide synthesis. The LibertyPrime2.0 uses a single mode self-tuned microwave
reactor that drastically reduces amino acid coupling times while increasing coupling
yields. A fiber optic temperature probe and reaction vessel camera within the sealed
microwave cavity also ensure accurate temperature monitoring and complete waste
removal during coupling and deprotection cycles. The LibertyPrime2.0 can efficiently
synthesize long peptide fragments of up to 48 amino acids that are inaccessible by
manual peptide synthesis. It is critical for our proposed studies to investigate the
biophysical and biochemical effects of histone sumoylation and p53 methylation in
human chromatin. This supplement seeks to replace an existing Liberty Blue peptide
synthesizer that is no longer functional, which significantly limits our experimental
capabilities. Use of the proposed instrumental setup will enable the semisynthesis of
site-specifically modified histones and transcription factors, which will lead to the
identification of novel pathways underlying neoplasia. This will reveal new therapeutic
targets in a wide range of human cancers associated with the dysregulation of histone
and p53 modifications.

Public health relevance
PROJECT NARRATIVE Post-translational modifications of histones and transcription factors are critical to gene function and misregulated in several diseases. We are developing chemical strategies to investigate the biophysical and biochemical effects of histone sumoylation and p53 methylation in human chromatin. Our studies will reveal new mechanisms underlying chromatin regulation and provide new therapeutic targets in diseases arising from its misregulation.